One-click Automated 3D Treatment Planning for Radiopharmaceutical Therapy

Radiopharmaceutical therapy (RPT) is an alternative cancer treatment to chemotherapy that has
worked well in patients with lymphoma, late-stage, metastatic prostate cancer, and
neuroendocrine tumors. A unique characteristic of RPT is that it is possible to calculate how much
radiation energy is deposited in tumors and normal tissues within an individual patient
(“dosimetry”) by imaging the radiation emitted by the RPT agent within the body. We know that
patient-specific prescriptions based on absorbed dose lead to better patient outcomes. Our active
Phase 2 SBIR grant aims to provide seamless integration and automation of RPT dosimetry in
clinical practices that are currently ill-equipped in terms of expertise and resources to perform
advanced dosimetry for RPT. To address this need we are integrating our dosimetry algorithm
into an automated treatment planning solution, TorchTM, by adding additional features such as
image registration, contour propagation, and pharmacokinetic modeling. However, we have
identified that a lack of region of interest (ROI) segmentation is an important feature gap in the
software. To address this need, Vox is requesting supplemental funding to achieve the following
aims: (1) Develop free-hand and threshold-based segmentation tools to create and edit binary
label volumes for normal organs and tumors in Torch. (2) Validate free-hand and threshold-based
segmentation tools to create and edit binary label volumes for normal organs and tumors in Torch.
Adding segmentation tools to Torch will help Vox achieve the overall goal of the Phase II SBIR
award of making RPT treatment planning faster and more accurate.

Public health relevance
We aim to develop software tools that will aid the user in better defining regions (ROIs) of interest in medical images. These tools will provide means to manually draw ROIs as well as semi-automatically or automatically highlight regions of the image which exhibit similar image intensities.